WHOLE BODY CALCIUM DETERMINATION USING A NORLAN XR26 BONE DENSITOMETER

The use of bone densitometry for monitoring metabolic bone disorders has been accepted as a clinically valuable tool. Measurement of total body mineral content by DEXA is a valuable diagnostic tool for the evaluation of metabolic bone disease. Whereas, it provides more accurate information about skeletal mineral content than the information obtained by measuring the bone mineral content at the spine and hip.